Strengths and weaknesses in learning in mice with ASD risk genes

Summary
Autism spectrum disorder (ASD) has diverse presentation but can be characterized by at core by a) rigid and
repetitive behavior and b) social communication deficits. In recent decades, there is increasing confidence that
identified genetic differences contribute to ASD in humans and a number of high confidence risk genes have
been identified. These risk genes can be studied in mice. There is hope that convergent phenotypes and
endophenotypes will illuminate key features of ASD (Hyman, 2014). One striking current area of
convergence seen in mice with ASD risk genes is a gain of function in rotarod motor learning and
alteration in neurotransmission onto spiny projection neurons (SPNs) of the striatum (Hyman, 2014).
This was first observed in mice with neuroligin gene mutations (Rothwell et al., 2014), but has also been
observed in mice with Tsc1 and Tsc2 gene mutations (Benthall et al., 2021). Tsc2 (with some studies of Tsc1
for comparison) will be the central focus of this proposal.
Here we propose that a major diagnostic criteria for ASD observed in TSC patients - restricted,
repetitive patterns of behavior - is mediated by changes in the activity of basal ganglia circuits that
control the learning and updating of appropriate actions. Specifically, we hypothesize that Tsc2
haploinsufficiency leads to changes in corticalstriatal synapses and SPN activity that facilities striatal
dependent learning and makes updating learning more inflexible. In Aim 1 we will use
electrophysiological and structural imaging methods to test if specific connections are stronger in Tsc2 Het
mice than WT. We posit based on studies in the dorsolateral striatum that corticostriatal connections onto D1R
expressing SPNs (dSPNs) will be enhanced in the dorsomedial striatum (DMS). Aim 2 will focus on behavior
and test in two different tasks if behavioral inflexibility in Tsc2 Het mice can be ameliorated by reducing reward
probability during learning. Aim 3 will use in vivo imaging in the striatum to examine how dopamine and striatal
activity may differ in Tsc2 mice under conditions that produce behavioral differences.
In sum, these data will inform basic neurobiology surrounding a convergent gain of function phenotype seen in
many ASD models: gain of function in striatal learning (rotarod being the most common test). We will translate
this learning phenotype into more translatable behavior learning paradigm--cue guided action learning and
seek the neural correlates of this gain of function. Finally, we will test a highly translatable therapeutic idea, the
idea that using lower reward probability during training will ameliorate neural differences and allow for greater
flexibility later.

Public health relevance
Narrative Learning is central to behavioral therapies for autism spectrum disorder (ASD). Differences in learning may also underlie the rigid and repetitive behaviors that often manifest in behavioral inflexibility in people with ASD. Therefore, it is of great interest to understand how learning and behavioral flexibility and associated neural functions are altered by autism risk genes.